CORE--BIOINFORMATICS AND BIOTECHNOLOGY

DESCRIPTION (provided by applicant): The Bioinformatics & Biotechnology Shared Resource provides a broad range of chemistry, biomolecular, and bioinformatics services and expertise in support of Cancer Center research programs. It includes six sections: Bioinformatics, High-throughput DNA Sequencing and Genotyping, Macromolecular Synthesis, Functional Genomics, Clinical Applications Core Technology (CACT), and Proteomics. Bioinformatics provides investigators with access to high-performance computing resources, bioinformatics software, and all major public biomolecular databases. High-throughput DNA Sequencing & Genotyping provides investigators with access to automated DNA sequence analysis, fragment size analysis, and SNP detection technologies. Macromolecular Synthesis provides synthetic peptides and synthetic oligonucleotides to Cancer Center investigators (CCSG support is not be requested for this section). Functional Genomics provides cDNA microarray services and analyses to Center investigators. The Clinical Applications Core Technology section provides oligonucleotide-based microarray analysis (Affymetrix, Inc.) for investigators. (Functional Genomics and the CACT laboratory activities will be combined in this application). Proteomics offers a range of protein chemistry capabilities including protein sequence analysis using Edman chemistry, protein identification using mass spectrometry, and protein interaction analysis using surface plasmon resonance technology. All sections are highly integrated and readily accessible using our Web-based on-line ordering and tracking system and a comprehensive relational database system housing all chemistry information.